Basis of Glutamatergic Synaptic Dysfunction in Schizophrenia

PROJECT SUMMARY/ABSTRACT
Genetic studies identify glutamatergic synaptic alterations as a core etiological mechanism of schizophrenia
(SZ). Consistent with genetic findings, in vivo and postmortem brain studies identify alterations to molecular,
structural and physiological markers consistent with deficient cortical glutamate synaptic neurotransmission.
However, the nature of synaptic impairments in SZ at individual cortical glutamate synapses, the most basic unit
of neural communication, is unknown. Interrogating measures of pre- and postsynaptic functioning at individually-
resolved synapses can provide unprecedented insight into the basis of synaptic dysfunction in SZ. Analysis at
this level of resolution requires an electron microscopic approach to directly visualize synaptic structures and
quantify ultrastructural correlates of pre- and postsynaptic functions. Despite the potent interpretative power
provided by ultrastructural analyses of individual synapses, multiple technical and logistical barriers have
prevented the large-scale application to study brain tissue in SZ. We have now developed a workflow permitting
three-dimensional (3D) quantitative and nanometer resolution imaging of glutamate synaptic structures via
focused ion beam-scanning electron microscopy (FIB-SEM) in postmortem human brain. Thus, in Aim 1, we
determine the effect of SZ on ultrastructural correlates of core pre- and postsynaptic processes in individual
glutamate synapses located in layer 3 (L3) of dorsolateral prefrontal cortex (DLPFC), a locus of in vivo functional,
structural and molecular abnormalities in SZ. Because synaptic signaling requires substantial energy produced
by mitochondria localized to synaptic structures, and reduced glutamatergic signaling lowers ATP demand and
synthesis at the synapse, ultrastructural analysis of mitochondria localized to glutamate axon terminals informs
the relative level of activity at individual synapses. Indeed, mitochondrial abundance, size and morphology
change in direct response to altered energetic demand at synapses. Thus, in Aim 2, we use our FIB-SEM
approach to quantify ultrastructural correlates of mitochondrial activity in each glutamate synaptic structure
identified in Aim 1. Finally, synaptic structure and function are directly regulated by synaptic protein levels. As
such, the molecular basis of the synaptic and mitochondrial ultrastructural alterations identified in Aims 1-2 can
be informed by proteomic analyses of DLPFC L3 synaptosomes. We have optimized a high throughput workflow
to quantify thousands of proteins in synaptosome preparations from DLPFC L3. Thus, in Aim 3, alterations in the
DLPFC L3 synaptic proteome in SZ are identified, quantified and mapped to ultrastructural alterations identified
in Aims 1 and 2. Our proposed studies will directly inform the structural and molecular bases of cortical glutamate
synaptic dysfunction in SZ at an unparalleled level of resolution to inform future functional pathway and molecular
therapeutic targets for cortical and cognitive dysfunction in SZ.

Public health relevance
PROJECT NARRATIVE Although cortical glutamate synaptic impairments are considered a core pathophysiological feature underlying brain dysfunction in schizophrenia, the nature of these synaptic impairments in schizophrenia is almost completely unknown. This project investigates the schizophrenia disease effect on presynaptic, postsynaptic and mitochondrial ultrastructural correlates of function at individual glutamate synapses using a focused ion beam- scanning electron microscopy approach, and molecular perturbations underlying these findings using a synaptosome proteomic approach, in postmortem human brain. These studies will determine the structural and molecular bases of cortical glutamatergic synaptic impairments in schizophrenia to inform functional and molecular therapeutic targets.